Peroxisome Biogenesis in Anti-Tumor T Tell Metabolic Fitness

ABSTRACT
Cancer remains a leading cause of mortality globally, particularly among aging populations. While adoptive T
cell transfer therapy (ACT) has shown promise in treating hematological malignancies, its efficacy against solid
tumors is hindered by tumor-induced immunosuppression. A significant contributor to the failure of ACT is the
exhaustion and dysfunction of T cells upon exposure to the hypoxic and lipid-rich tumor microenvironment (TME).
Peroxisomes, organelles involved in regulating fatty acids and reactive oxygen species, have been implicated in
cellular functions, yet their role in anti-tumor T cell responses within the TME remains poorly understood. Our
preliminary data shows a reduction in peroxisome levels and antioxidant enzyme catalase in T cells exposed to
the TME, correlating with increased exhaustion markers, suggesting peroxisome deficiency may be limiting T
cells ability to overcome TME oxidative stress. The overarching goal of this study is to elucidate the impact of
peroxisome biogenesis on adaptive immune responses, particularly within the TME and anti-tumor immunity.
We hypothesize that T cells with enhanced peroxisome capacity will exhibit increased antioxidant defenses and
improved interactions with other organelles, thereby enhancing their resistance to lipid-mediated stress and
persistence within the immunosuppressive TME. This hypothesis will be tested through two integrative specific
aims. Specific Aim 1 aims to delineate the mechanisms by which peroxisome capacity influences T cell
exhaustion, lipid accumulation, and organelle interactions. We anticipate that T cells with elevated peroxisome
levels will demonstrate enhanced anti-tumor activity through regulation of catalase and lipid intermediates, and
by maintaining interactions with key organelles to mitigate oxidative stress and lipid peroxidation. Specific Aim 2
seeks to establish optimal in vivo conditions for promoting peroxisome capacity to generate exhaustive-resistant
anti-tumor T cells. We expect that enhancing peroxisome capacity will improve T cell persistence and mitigate
exhaustion in the TME. This will be investigated through ACT experiments using melanoma and Burkitt
lymphoma models, employing strategies to augment peroxisome quantity and catalase levels. The findings from
this study will provide novel insights into the role of peroxisomes in modulating T cell function and anti-tumor
immunity. By uncovering mechanisms to enhance ACT efficacy through peroxisome manipulation, this research
holds translational potential for improving cancer immunotherapy strategies beyond ACT, including immune
checkpoint blockade therapy.

Public health relevance
PROJECT NARRATIVE This project aims to investigate the role of peroxisomes in enhancing anti-tumor T cell function within the tumor microenvironment. By elucidating mechanisms through which peroxisome biogenesis influences T cell exhaustion and interactions with other organelles, we seek to improve adoptive T cell transfer therapy (ACT) efficacy against solid tumors. These findings hold promise for developing novel strategies to enhance cancer immunotherapy by leveraging peroxisome modulation to overcome tumor-induced immunosuppression.